Photoperiodic Programming of Monoamine Brain Circuits

PROJECT SUMMARY
A fundamental question in neurobiology is how environmental signals – both developmental and ongoing–
induce plasticity in neural circuits and networks to shape behavior. Circadian photoperiod, the proportion of
daylight in a solar day, is a pervasive environmental signal that varies substantially with latitude and season,
and drives acute and long-term effects on mood regulation in humans and in animal models. The associations
of the molecular circadian clock and photoperiod with mood disorders are clear, but the neurobiological
mechanisms remain incompletely understood.
The serotonergic dorsal raphe nuclei (DRN) are a critical nexus for integrating circadian photoperiodic input
with mood and reward. They receive light input from the circadian visual system and polysynaptic input from
the biological clock nuclei and make widespread outputs, including to midbrain nuclei mediating motivation and
reward through dopaminergic transmission. Seasonal photoperiods (winter–like “short days” vs. summer-like
“long days”) induce enduring changes in mouse DRN serotonin neurons - programming their excitability and
intrinsic electrical properties, their serotonin content, as well as anxiety and depressive-like behaviors. We
have previously shown that the TREK-1 K+ channel mRNA expression is photoperiodically regulated in DRN 5-
HT neurons, and therefore may play a key role in photoperiodic programming of serotonin excitability. A
number of independent lines of evidence indicate that TREK-1 in DRN neurons impact mood regulation and
mood disorders. We now also report intriguing sex-dependent photoperiodic regulation of dopamine uptake
and release downstream of the DRN in the NAc of female mice, indicating photoperiodic impact on circuitry for
motivation and reward that mirrors the reported female bias of Seasonal Affective Disorder (SAD) in humans.
We propose as our overall hypothesis that DRN 5-HT neurons are a primary site of photoperiodic
programing – in which transcriptional regulation of TREK-1 plays a key role in regulating neuronal
excitability. In congruence with the NIMH RDOC paradigm, we envision photoperiod programing as an
extended circuit for positive valence system behaviors in which the output of the programmed serotonergic
DRN induces convergent drive by the DRN and VTA inputs to alter NAc function, driving changes in the output
of reinforcement/motivated behaviors. We will further elucidate a mechanistic basis of photoperiodic
programming of 5-HT neurons involving TREK-1, and downstream effects of this programming on
positive valence systems, including NAc dopamine release and uptake, NAc synaptic plasticity, and
NAc-driven motivation behavior. Completion of these Aims will enhance understanding of key
neurobiological mechanisms underlying photoperiodic regulation of mood, motivation, and reinforcement.

Public health relevance
PROJECT NARRATIVE Environmental signals that influence brain function and development play critical roles in the neural basis of mental disease. Light has long been recognized as a powerful environmental influence on specific brain regions, and we have recently demonstrated that circadian photoperiodic light cycles persistently alter the function of the brain’s serotonin neurons along with depressive and anxiety-like behaviors. Here, we will combine electrophysiological, molecular, and behavioral experiments to examine how circadian photoperiodic light exposure programs serotonin/glutamate neurons of the dorsal raphe nucleus through the modulation of the ion channel TREK-1, and exerts downstream influence on dopaminergic and glutamatergic circuits in the nucleus accumbens relevant to anxiety, depression, and reward-based behaviors.